NITRIC OXIDE ACTION IN PRIMATE MYOMETRIUM

DESCRIPTION (Adapted from the Investigator's Abstract): In this twice revised new R29 application, Michael E. Bradley, Ph.D. requests $350,000 in direct costs over 5 years to study the "molecular basis of nitric oxide action in primate myometrium." The long-term goal of this project is to understand the signals responsible for commencement of uterine contractions associated with labor. The specific aim of this proposal is to determine if the tissues of the human or monkey uterus produce nitric oxide and whether nitric oxide can relax human or monkey uterine myocytes. The proposal is divided into 2 specific aims. In specific aim 1 the investigator will determine the effects of exogenous NO in non-pregnant, near term pregnant, and laboring uterine tissues and cells. In this specific aim the investigator will determine the effects of NO on myometrial tissue tension and determine the effects on NO on the concentration of calcium, cAMP and cGMP. In specific aim 2 the investigator will characterize, localize and investigate the regulation of NOS isoforms in the primate uterus. Techniques to be explored in this specific aim include Western blot analysis of intact tissues and cultured cells and determination of NOS mRNA expression using RT-PCR.